Down Syndrome Clinical Cohort Coordinating Center (DS-4C) for the INCLUDE Project

PROJECT SUMMARY/ABSTRACT
The overarching goal of the proposed INCLUDE Clinical Cohort Coordinating Center (DS-4C), co-led by
investigators at RTI International and Emory University, is to improve the health and well-being of individuals
with Down syndrome (DS) by supporting the INCLUDE Project’s DS Cohort Development Program (DS-CDP).
In this capacity, the DS-4C will serve as the central hub for orchestrating and integrating all components of the
DS-CDP, including overseeing the development and implementation of a common protocol to guide
harmonized data collection across multiple DS Cohort Research Sites (DS-CRS) in the DS-CDP and
facilitating data transfer into the INCLUDE Data Coordinating Center (DCC) and Data Hub for availability to
researchers. The complex structure of the DS-CDP requires the DS-4C’s expert leadership and coordination to
generate an effective, integrated, unified network to achieve the goal of generating deep phenotyping data and
collecting biospecimens in a large, diverse cohort of individuals with DS across the lifespan to support future
research efforts to improve DS-associated co-morbidities. The four cores of the DS-4C (Administrative, Cohort,
Outreach, and Data Management) will leverage the expertise of core staff and work collaboratively to provide
administrative support to facilitate collaboration and communication across the DS-CDP; ensure seamless
implementation of the protocol; implement and support inclusive outreach efforts to facilitate inclusion and
representation in recruitment; and manage the flow of data and biospecimens from the DS-CRS to the
INCLUDE DCC and Data Hub and DS-Biorepository, respectively. Our specific aims are as follows:
Aim 1: Implement tools and systems to foster seamless integration and operational efficiency within the DS-4C
and across the DS-CDP.
Aim 2: Provide expertise and resources to develop and implement the common protocol across the DS-CDP
while enhancing the scientific rigor of DS-CRS studies to maximize the scientific impact of the INCLUDE Project.
Aim 3: Enhance community engagement, facilitate recruitment of participants and team members from typically
underrepresented groups, advance health equity goals, and promote awareness of the INCLUDE Program.
Aim 4: Manage the flow of data from DS-CRS into the INCLUDE DCC and Data Hub for access by the DS
research community.
The DS-4C will be led by Multiple Principal Investigators, Dr. Hunter at RTI and Dr. Rosser at Emory, with a
collaborative history and extensive expertise in elucidating health outcomes of individuals with DS through
phenotypic protocol development, biospecimen collection, multi-site recruitment efforts, and data
harmonization. The proposed DS-4C is immediately and amply prepared to support its mission to develop
clinically meaningful findings that positively impact those affected by DS.

Public health relevance
Project Narrative Down syndrome (DS) is the most common genetic form of intellectual disability and is associated with an increased risk for many adverse health outcomes, including structural heart defects, sleep apnea, thyroid abnormalities, hearing and vision problems, and early-onset dementia. NIH’s INvestigation of Co-occurring conditions across the Lifespan to Understand Down syndromE (INCLUDE) Project is funding a broad effort to collect data from a large group of people with DS across a range of ages and backgrounds to help researchers understand why individuals with DS are more likely to have these conditions, which will help guide treatments and interventions to improve their health and well-being. The INCLUDE Clinical Cohort Coordinating Center will play an important role in this effort by working with cohort collection sites to capture data from a wide range of health conditions and make sure these data are submitted to the INCLUDE Data Coordinating Center, where it will be accessible for researchers.